Comparative Genomic Analysis of Clostridium perfringens

DESCRIPTION (Applicant’s Abstract): Clostridium perfringens has a long history of being associated with a high level of morbidity and mortality in battlefield and clinical settings, due to its ability to produce a wide range of deadly toxins and cause diseases such as gas gangrene and enteric infections. C. perfringens has also been tested as a potential biological warfare (BW) agent in World War II and the Iraqi government is suspected of attempting to develop C. perfringens as a BW agent before the Gulf War. Because most of the genes encoding the toxins have been cloned and sequenced, it is feared that these may be used to produce these toxins on a large scale and inflict casualties on military and civilian populations. In addition, C. perfringens is genetically tractable and is capable of producing a heat resistant spore; these qualities make it an inviting target for developing BW methods for producing and delivering deadly toxins. The information obtained from genomic sequencing of C. perfringens will permit the development of vaccines and diagnostic reagents that can be used to combat and diagnose the disease caused by this bacterium. The genetic sequence will also allow production of DNA microarrays, to determine which genes are turned on in infections and identify host specificity factors that differentiate human and veterinary pathogenic strains. The genome sequence will also provide important information on fundamental biological processes such as spore production and basic metabolism in the Clostridia.